Improving intracortical control of reaching after paralysis

Abstract
Spinal cord injury resulting in paralysis affects more than 250,000 people nationwide with over
12,000 new cases each year. More than half of all SCIs occur at cervical levels resulting in paralysis
below the neck with less than 1% achieving full recovery. Paralysis results in a loss of independence,
and the need for caregiver assistants to perform activities of daily living. This loss of independence
adds to the emotional, financial, and family burden of this chronic condition.
Hardware is now available that holds the potential to restore lost arm function after spinal cord
injury. Specifically, tiny arrays of implanted intracortical microelectrode are able to detect the neural
firing patterns in the areas of the brain responsible for producing reaching movements. Also
implanted stimulating electrodes implanted on or near the peripheral nerves are able to reanimate
muscles after paralysis. Combining these implanted recording and stimulation technologies holds the
potential to restore arm movement controlled by one's own thoughts. However, much work is needed
to refine the control algorithms that translate the brain signals into the stimulation patterns needed to
make the desired movements.
This study will evaluate three methods of improving control algorithms for restoring reaching in
both human and animal models. Specifically we are exploring options for controlling not only the
motion of the limb, but also how well the limb resists perturbations from external forces. Increasing
limb `stiffness' by activating opposing or `antagonist' muscles will help to stiffen and stabilize the limb
making it resistant to unintended movement if bumped. In the first method, we are incorporating
automated stiffness control based on context (i.e. limb stiffness is modulated based on the intended
speed and acceleration/deceleration we decode from the brain signals). In the second method, we
will extract a separate `stiffness' command signal from the brain and use that cortically-derived
command to adjust limb stiffness in real time. In the third method, we put individual recorded neurons
in direct control of the muscle stimulators using a simple linear brain-to-muscle-stimulator mapping.
This method puts the brain in charge of learning with practice how to optimize muscle activation to
modulate stiffness as needed. Optimizing how stimulation is delivered to control stiffness is important
for practical use of this technology because too little stiffness will allow the arm to be easily bumped
off course whereas more stiffness than is needed will waste stimulator batteries and can cause
muscle fatigue.

Public health relevance
Project Narrative Spinal cord injury resulting in paralysis affects more than 250,000 people nationwide. Implant technology is now available to infer one's desired movement from signals recorded from microelectrode arrays implanted in the brain areas that control movement. Implanted stimulation technology can now reanimate paralyzed muscles, and combining these technologies has the potential to restore reaching movements by thought after paralysis. The goal of this study is to improve stimulation control algorithms to optimize limb motion and stability while also minimizing fatigue and conserving battery power.